INSULIN KINETIC BEHAVIOR IN OBESE MAN

An oral glucose tolerance test will be performed pre weight loss, and post weight loss in obese patients recruited from the OBESITY and RISK FACTOR PROGRAM of St.Joseph Medical Towers, (Drs. Goldman, Cronin, Erickson, Lubash). The C-peptide and insulin data will be used to model insulin physiology and determine hepatic insulin extraction. Question 1) Is hepatic insulin extraction reduced in obesity leading to the peripheral hyperinsulinemia? 2) If present, is this abnormality corrected with weight reduction?